Prescribe to Prevent HIV

In the U.S., the 3.6 million people who inject drugs (PWID) are facing an urgent preventable health crisis of
rising severe injection-related infections (SIRI), including HIV, due to limited access to two high-priority harm
reduction evidence-based interventions: sterile injection equipment and daily oral Pre-exposure prophylaxis
(PrEP). Many PWID lack access due to shortages of syringe service programs and clinicians willing to
prescribe these interventions. For instance, PWI D in Pennsylvania experienced a 150% rise in acute HIV
infections from 2016 to 2019, and a 250% rise in SIR I-related hospitalizations since 2010. Outpatient clinics
provide a more accessible venue for implementing harm reduction interventions, and research shows that
prescribing injection equipment and PrEP in these settings can reduce SI RI-related hospitalizations by 30%
and enhance PrEP uptake among PWID. However, most outpatient clinicians do not offer either, exacerbating
the evidence-to-implementation gap and contributing to the ongoing crisis. The "Prescribe to Prevent HIV'
(P2PH) trial, aims to co-create and pilot test a strategy bundle for prescribing injection equipment and PrEP
across four Pennsylvania Centers of Excellence (COEs) outpatient clinics, integrating implementation science
with human-centered design while engaging a community collaborative of individuals with lived experience,
clinicians, and community organizations serving PWID throughout all study phases. This will be achieved
through two independent aims: Aim 1 focuses on developing a multi-level implementation strategy bundle by
identifying barriers and facilitators through 24 semi-structured interviews using the Consolidated Framework for
Implementation Research, followed by co-creating the bundle through a user-centric design approach during
four focus groups with COE patients and clinical partners. Aim 2 involves pilot testing the implementation
bundle in a cluster-randomized, waitlist-controlled design to assess clinician adoption and maintenance of
prescribing injection equipment and PrEP, alongside secondary outcomes like SI RI-related hospitalizations and
negative HIV tests. Completion of these aims will lay the groundwork for a fully powered cluster-randomized
hybrid type 3 trial to test implementation strategies to sustainably enhance outpatient clinic-based prescribing
of injection equipment and PrEP for PWID. This proposal will be supported by strong institutional backing and
a dedicated mentorship team, along with coursework and experiential learning focused on the methodological
and conceptual aspects of conducting research in community-engaged implementation science and clinical
trials. Together, these research and career development plans will support my long-term career goal of
becoming an independent clinician-investigator and a leading national expert in the implementation of harm
reduction evidenced-based interventions in general medical settings.

Public health relevance
In the U.S., the 3.6 million people who inject drugs (PWID) are facing a growing preventable health crisis of rising severe injection-related infections (SIRI), including HIV, due to limited access to two high-priority interventions: sterile injection equipment and daily oral PrEP. Outpatient clinics that treat addiction represent an opportune venue to implement these interventions, yet most outpatient clinicians do not offer them, exacerbating this wide evidence-to-implementation gap. The Prescribe to Prevent HIV (P2PH) trial is a participatory study to co-create and pilot test a tailored multi-level implementation strategy bundle to increase the prescribing of sterile injection equipment and PrEP in four outpatient clinics, ultimately reducing the risk of HIV and SIRI among PWID.